PREFRONTAL CONTROL OF SOCIAL BEHAVIOR IN NON HUMAN PRIMATES

Cocaine abuse continues at an epidemic level with significant costs to society, yet no medication for cocaine abuse has demonstrated effectiveness for long-term use. The current project utilized a nonhuman primate model of drug self-administration in conjunction with in vivo microdialysis to study the neurochemical effects of cocaine. Marked elevations in dopamine were observed during drug-seeking behavior prior to drug delivery, demonstrating the importance of behavioral and environmental influences on brain chemistry during drug use. Moreover, the potent and selective dopamine transporter inhibitor, RTI-113, effectively reduced cocaine self-administration while exhibiting a profile of behavioral effects that is desirable for a substitute medication. These promising results suggest that the dopamine transporter is a potentially useful target in the pharmacological treatment of cocaine abuse. FUNDING Yerkes / Venture Funding $20,000 1/01/98 - 12/31/99 PUBLICATIONS *Czoty, P.W., Justice, J.B. and Howell, L.L. Cocaine-induced changes in extracellular dopamine determined by microdialysis in awake squirrel monkeys. Psychopharmacology (In press). P51RR00165-38 1/1/98 - 12/31/98 Yerkes Regional Primate Research Center